Antifungal antagonism as a cause of treatment failure for invasive mycoses

An estimated 1.5 million people die each year from invasive fungal infections (IFIs), with millions more afflicted
by debilitating mucosal and subcutaneous mycoses. Current antifungal therapies have serious deficiencies
including limited spectrum of activity, patient toxicity and the emergence of fungal isolates with genetically
encoded resistance. A larger concern is the modest efficacy of all three major classes of antifungal drug, as
this is likely a major driver of the excessively high rates of mortality in patients with IFIs, and persistence of
mucosal infections. For unexplained reasons, the majority of treatment failures occur in patients infected by
fungal isolates that are seemingly sensitive to the selected antifungal therapy, as determined by in vitro
susceptibility testing. For example, approximately one-third of patients with a disseminated Candida infection
involving isolates deemed susceptible according to current clinical breakpoints, fail to respond to treatment with
an azole antifungal. Several host-related factors have been proposed to explain the discordance between in
vitro susceptibility tests and patient outcomes, such as inadequate drug distribution to the site of infection or
severity of patient immune dysfunction. However, there is only limited evidence to support these arguments,
and many treatment failures remain unexplained. While drug-drug interactions are a serious concern from the
perspective of patient toxicity, the effect of most co-administered medications upon fungal physiology and
antifungal susceptibility, is largely unknown. Using a simple screen of mainly off-patent medications, we
recently found that a staggering 139 of the 1280 compounds examined exhibit antagonistic interactions with
fluconazole in at least one medically important Candida species. Our preliminary studies have also revealed
that non-antifungal medications can have a profound impact upon fungal physiology and upon the outcome of
infection in mice. The objective of this study is to uncover the full scope of antifungal drug-drug antagonistic
interactions and assess their potential clinical impact upon treatment outcomes in patients with IFIs. In aim 1
we will conduct a comprehensive and systematic set of screens to identify currently approved medications that
antagonize the activity of the most relevant antifungal drugs, in four of the most prevalent human fungal
pathogens. Those acting at pharmacologically relevant concentrations will then be selected, and the extent to
which antifungal activity is diminished compared. Aim 2 will focus upon defining the molecular mechanisms by
which antifungal antagonists act and examine their effects upon fungal physiology. Finally, in aim 3 we will use
a mouse model of invasive candidiasis and conduct a retrospective analysis of patient outcomes to determine
if coadministration of antagonistic drugs is sufficient to influence the clinical efficacy of antifungal therapy. The
long-term goal is to improve patient outcomes through establishing integrated treatment protocols that
minimize clinically relevant antagonistic drug-interactions to and therefore maximize antifungal efficacy.

Public health relevance
The mortality rates associated with many invasive fungal infections remain disturbingly high, despite the appropriate use of three major classes of antifungal drug. Recently we found that many medications approved for human use can induce resistance to first-line antifungal drugs, suggesting their coadministration may undermine the clinical efficacy of antifungal therapy. Ultimately the findings of the proposed studies will be used to guide the selection of drug regimens and develop treatment protocols that maximize antifungal efficacy, to improve outcomes for patients with life-threatening fungal infections.